Leadership, Planning and Evaluation

PROJECT SUMMARY/ABSTRACT
Part I: Planning and Evaluation
It is understood by the senior leadership of The Tisch Cancer Institute (TCI) that continually
assessing and reevaluating its objectives and processes is needed to ensure that resources are
being strategically directed towards achieving the greatest benefit for cancer patients and research.
To facilitate the strategic growth of the TCI at Mount Sinai, there has been a focus on utilizing both
external experts and transparent internal processes to ensure a robust planning and evaluation
process. These internal and external systems, including External Advisory Board meetings and
internal retreats, planning and evaluation committees, and seminar series have allowed TCI
leadership to develop a clearer roadmap for facilitating collaboration, optimizing investments and
recruiting strategically.
Part II: Senior Leadership
The TCI senior leadership structure includes a Director, Deputy Director, Executive Administrator and
eight Associate Directors. This senior leadership team is responsible for establishing a vision for the
cancer center and for addressing the center’s overall goals, policies and operations.